The Paracrine Regulation of Mast Cells During Biliary/Cholangiocyte Repair and Damage

Cholangiopathies, including primary sclerosing cholangitis (PSC) are cholestatic liver diseases that target
cholangiocytes. No definitive treatments for PSC exist and curative measures are elusive, thus translational
studies are critically needed. PSC is characterized by ductular reaction (DR) encompassing enhanced bile duct
mass, biliary senescence, inflammation, peribiliary fibrosis and increased portal mast cell (MC)
presence/activation. During liver damage, MCs migrate to the liver and reside near damaged/senescent bile
ducts and inhibition of biliary-derived senescent associated secretory phenotypes (SASP) reduces PSC
phenotypes in mice. The exact source of MC infiltration/activation or stabilization remains unclear. Melatonin
exerts its effects via specific receptors, MT1 and MT2, which are expressed by cholangiocytes and upregulated
in cholestasis but have differential effects on liver damage. Knockdown of MT1 decreases cholestatic liver injury,
whereas knockdown of MT2 increases cholestatic liver injury. Anti-inflammatory and anti-oxidant properties of
melatonin are well-known; however, melatonin can also inhibit HA signaling, suggesting a link between these
two molecules that, to date, has remained elusive. One key element between melatonin signaling and MC-
histamine (HA) is the alarmin and SASP, IL-33, which is the ligand of the ST2 receptor (expressed on MCs) and
IL-33/ST2 are upregulated in cholestasis. Since melatonin modulates IL-33/ST2 signaling which regulates MC
activation/stabilization, there is a natural link between these two. Preliminary data demonstrates that (i) IL-33/ST2
signaling increases in human PSC and Mdr2-/- mice that correlates with increased HA content; (ii) Mdr2-/- mice
treated with an ST2 inhibitor have reduced DR, inflammation and IL-33 content; and (ii) melatonin therapy
decreases MC activation and biliary IL-33 content. These data support our overall hypothesis that, during liver
damage, increased systemic and hepatic IL-33 levels induce MC infiltration/activation driving PSC phenotypes,
which can be ameliorated via modulation of melatonin/MT-1 signaling. SA1 Hypothesis: Hepatic IL-33/ST2
signaling drives MC infiltration/activation and PSC phenotypes. We will evaluate (i) the cellular source(s) of IL-
33 using in vivo models and in vitro systems; and (ii) effects of IL-33/ST2 modulation on MC migration/activation
and PSC phenotypes. SA2 Hypothesis: MCs infiltration increases IL-33 during liver damage and manipulation
of MC mediators decreases IL-33/ST2 signaling. We will determine if (i) manipulation of MC-HA signaling directly
alters IL-33/ST2 signaling, using cultured systems and 3D human organoids; (ii) changes in MC-HA/HR signaling
in vivo mediates IL-33/ST2 outcomes and (iii) if manipulation of MCs in vitro affects PSC phenotypes. SA3
Hypothesis: Exogenous melatonin or manipulation of melatonin signaling decreases liver damage by stabilization
of MCs and downregulation of IL-33/ST2 and there is an autocrine regulation of biliary melatonin that may reduce
MC activation and IL-33/ST2. We will measure (i) effects of melatonin therapy on PSC outcomes; (ii) autocrine
effects of biliary melatonin on IL-33/ST2 and disease phenotypes.

Public health relevance
PSC is a complex cholestatic liver disease with limited treatment options and dismal prognosis and biliary senescence induces mast cell (MC) migration which promotes PSC progression, in vivo. IL-33/ST2 signaling is upregulated in cholestatic injury and induces MC migration/activation. Melatonin therapy decreases PSC phenotypes and inhibits MC activation through changes in IL-33/ST2 signaling and NFB translocation.